EFFECT OF INTRAVENOUSLY ADMINISTERED EPINEPHRINE ON CARDIAC REPOLARIZATION

In this pilot project, the effect of epinephrine on cardiac repolarization, as indicated by the QT interval in the surface ECG, will be studied. The dose-response relationship for QT prolongation by intravenously administered epinephrine will be obtained.